Defining the HIV reservoir and latency mechanism in human brain myeloid cells

SUMMARY
It has yet to be determined whether human brain myeloid cells (BMCs) serve as an important reservoir for
persistent HIV-1 (HIV) infection in the central nervous system (CNS). This is hampered by the challenges faced
in accessing fresh human brains. Therefore, our current knowledge of HIV CNS reservoirs in humans is largely
limited to in vitro microglia/macrophage models of HIV latent infections and animal studies from SIV-infected
NHP or HIV-infected humanized mouse models. There is an urgent need for innovative HIV latency models of
BMCs that are physiologically close to the cells in the human brain. By working with the “Last Gift” Program, we
have established a platform to isolate, expand, and characterize BMCs derived from people with HIV (PWH) on
antiretroviral therapy (ART). We showed that a near full-length HIV can be recovered from BMCs, which was
replication-competent in both T cells and BMCs. Bioinformatics analyses predicted the R5 tropism of this BMC
HIV strain, which was confirmed by in vitro infection in BMCs, during which BMC infection by this strain of HIV
was effectively dampened by a CCR5 inhibitor, Maraviroc. Pseudoviruses of Env cloned from this strain of BMC
HIV efficiently infected CD4low but CCR5high affinofile cells, supporting its M-tropism nature. Interestingly, human
BMCs expressed the newly identified HIV latency gene Nurr1 as well as anti-apoptosis genes, including Bcl-2
and MCL1, which could be essential for the stable HIV reservoir in BMCs.
With the needed expertise to successfully isolate CNS cells (CNS T cells and BMCs) from postmortem fresh
brains, technical innovations of single-cell technique pipelines, and the unique and rare resource of the “Last
Gift” cohorts, this proposal will define the mechanism underlying the stable replication-competent HIV
reservoir in BMCs. We will isolate BMCs from the brains of ART-suppressed PWH. We will define replication-
competent HIV through de novo infections in T cells and BMCs as well as BMC-QVOA and T cell-QVOA
analyses. We will genotype BMC HIV by single genome amplification sequencing and phenotype it by Env-
pseudoviral infections in cells expressing low levels of CD4. We will characterize the transcriptionally active HIV
as a possible viral reservoir in BMCs (Aim 1). In Aim 2, we will define the survival signaling pathways that may
be acquired in the latently infected BMCs. We will study latency reversal using epigenetic modulators in BMCs.
We will define the mechanisms of the epigenetic regulation of BMC HIV. We will also test whether previously
identified BMC transcription factors play essential roles in HIV latency in postmortem BMCs. In Aim 3, we will
examine new tools to directly target the transcription machinery of HIV to control viral reservoirs and delay or
prevent viral rebound, which may also limit immune activation.
This proposal will address critical knowledge gaps in replication-competent HIV reservoirs in BMCs and
underlying molecular mechanisms. The tools and BBB-penetrating small molecules used in this proposal could
be developed into novel cure strategies to eradicate HIV from the CNS.

Public health relevance
Project Narrative It remains to be determined whether the central nervous system (CNS) harbors the replication-competent HIV. This study will define the latent HIV infection in the brain myeloid cells (BMCs) isolated from the fresh brains of people with HIV enrolled in the “Last Gift” Program receiving suppressive ART. We will characterize human BMCs, define the genotypes and phenotypes of BMC HIV, and define the epigenetic features of stable HIV reservoir in human BMCs by the state-of-the-art techniques, in which the tools and BBB-penetrating small molecules studied in the proposal can be developed to manipulate HIV from the CNS in the future.